Regulation of invadosome-mediated peripheral axon guidance by ErbB signaling

ABSTRACT
The development of the nervous system requires the proper differentiation, migration, morphogenesis and
maturation of neurons. The morphological differentiation of individual neurons and the assembly of the trillions
of neuronal connections that compose the human nervous system occurs through guided extension of axons
and dendrites. While many studies have investigated the molecular mechanisms that regulate axon guidance
over two-dimensional substrata in vitro or along axonal tracks in vivo, little is known about cues that control axon
guidance across three-dimensional tissues and through basement membranes. These are fundamental
questions as numerous distinct types of axons must penetrate basement membranes to enter diverse tissue
targets. Our preliminary and recently published data suggest that along with planar filopodia and lamellipodia,
growth cones generate orthogonal protrusions in vitro and in vivo that resemble podosomes or invadopodia.
Podosomes and invadopodia, collectively referred to as invadosomes, are distinct actin-based cellular
protrusions associated with extracellular matrix (ECM) degradation and tissue invasion. We hypothesize that
distinct ligands in the environment of growth cones promote invadosome formation, maturation and function.
Further, we hypothesize that mature invadosomes use microtubules to target matrix metalloproteases (MMPs)
to their cell surface and support local MMP secretion. Several compelling pieces of preliminary data suggest that
EGF ligands (EGF and Neuregulins), promote invadosome formation and maturation by motor and Rohon Beard
neuron growth cones, leading to ECM remodeling by MMPs and axon exiting the spinal cord. The three aims of
this proposal will use a series of molecular gain of function and loss of function manipulations, together with live
and fixed cell fluorescence imaging in vitro and in vivo, to assess the receptors/ligands, as well as the signals,
that control invadosome formation and their roles in driving peripheral axon exiting the spinal cord.

Public health relevance
NARRATIVE The development of a functional nervous system requires precise guidance of axons and dendrites to their target locations and mis-guidance of axons likely accounts for many neurodevelopmental disorders, while failure to regenerate axons often occurs after injury or disease. This proposal will focus on dissecting the role of invadosome-like protrusions from growth cones in the regulation of axon guidance through three- dimensional space. The aims of this study will examine the role of EGF ligands and ErbB receptors in the control invadosome formation and function in vitro, as well as test the role of invadosomes in targeting MMPs during peripheral axon guidance in vivo.